STRUCTURE OF N TERMINAL DOMAIN OF SIGNAL SEQUENCE RECOGNITION PROTEIN

Our current effort is directed towards obtaining larger crystals of the NG domain. Due to their small size, rapid decay, and relatively weak diffraction, further crystallographic characterization using laboratory X-ray sources may remain problematic. We are applying for time at SSRL in order to: 1) evaluate the diffraction limit and lifetime of the crystals, 2) collect sufficient data to sufficient resolution to convincingly determine the space group symmetry, 3) evaluate the feasibility of using cryo-methods for data collection, and 4) if possible, collect a complete data set.